Efficacy and safety of novel CD80 IL15 IL15Ra expressing autologous AML vaccines

DESCRIPTION (provided by applicant): Our goal is to improve survival in older acute myeloid leukemia (AML) patients using optimized, genetically engineered, autologous AML cell vaccines. Compelling evidence for the efficacy of immunotherapy in eliminating minimal residual disease (MRD) is provided by the superior outcomes of allogeneic hematopoietic stem cell transplants (HSCT) and donor leukocyte infusion (DLI) due to graft vs leukemia (GVL) effects. However, patients > 60 yo are often ineligible for allo-HSCT, due to co-morbidities or lack of a donor, and have dismal outcomes. Our hypothesis is that co-expression of IL-15 and IL-15Rα by autologous AML vaccines combined with CD80 expression, will elicit potent anti-leukemic responses that will improve relapse-free survival in older patients after remission induction. Mechanisms of resistance to immunotherapy include ineffective presentation of leukemia-specific or -associated antigens and inadequate effector cell activation. Previous efforts to improve antigen presentation of AML cells by in vitro differentiation into AML-derived dendritic cells were unsuccessful. However, transduction of AML to co-express the missing CD80 co-stimulator, and IL2 or GM-CSF, efficiently stimulates specific anti-leukemic immunity in murine AML and in human ex vivo assays. Despite approval in the UK, of a Phase-I trial using a CD80/IL2 expressing irradiated AML vaccines, concerns remain that IL2 expression may stimulate not only the activation of cytolytic T and NK cells, but also immune inhibitory T regulatory cells (Treg). Recently IL15, a γc chain cytokine that shares with IL2 the ability to stimulate NK and CD8+ memory T cells, has shown unique properties suited to stimulating anti-tumor immunity. IL15 is primarily trans-presented by cells expressing IL-15 receptor alpha (IL15Rα) to responding cells expressing IL15R subunits (IL2/15Rβ and γ common (γc) sub-units). IL15 improves memory CD8+ T cell expansion, shows less Treg induction than IL2, and can protect immune effectors from Treg suppression. Unlike IL2, IL15 does not cause activation induced cell death in stimulated T cells. Co-expression of IL15 with membrane-bound IL15Rα (mIL-15Rα), as a secreted complex (IL15/sIL15Rα), or as an IL15/IL15Rα fusion protein, greatly increases IL15 stability and efficacy. We have generated and will test tricistronic lentiviral vectors expressing CD80 and either 1) IL15/mIL-15Rα, 2) IL-15/sIL-15Rα, or 3) IL-15/IL-15Rα fusion protein to determine which is optimal for clinical trial. Ex vivo studies in Aim 1 will provde a head-to-head comparison of the specificity as well as the nature, and magnitude of anti-leukemia responses induced by co-culture of human immune effectors with irradiated, autologous AML cells, transduced with the test human IL-15 lentiviral vectors vs a control vector expressing human CD80/IL-2. In vivo studies in Aim 2 will test the safety, toxicity, and efficacy of parallel vaccines transduced with murine IL-15 vectors vs the IL-2 control vector against murine 32Dp210 leukemia. The AML vaccine with best safety and survival outcomes will then be tested in aged mice that recapitulate features of immune senescence. Studies will directly inform the design of a Phase 1 clinical AML vaccine trial at UCSF for patients >60, ineligible for HSCT.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relapse of acute myelogenous leukemia (AML) from residual disease is the major reason for poor survival outcomes, particularly in patients over 60 yo for whom there currently no effective treatment options. Our strategy is to activate the patient's immune system to attack and eradicate AML cells persisting after chemotherapy with an irradiated whole cell vaccine made from patient's leukemia cells genetically engineered to produce novel combinations of immunostimulatory factors. Information from the studies proposed will enable selection of the most effective AML vaccine design for a future clinical trial in older patients. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Our long-term goal is initiation of a Phase-1 immunotherapy trial of post-remission vaccination in older AML patients. Approximately 30-60% of adult AML patients under 60 survive, but in patients over 60 yo survival is less than 10%.8,9 The proposed studies address both the poor immunogenicity of AML cells as vaccine targets, and the diminished immune responsiveness to vaccines in older individuals. Previous studies (GVAX trial) in which we participated showed promise for autologous vaccine/cytokine-mediated immunotherapy for AML. However, the lack of adequate co-stimulation by AML blasts and their immunosuppressive activity were not addressed. Our current approach is to generate autologous AML vaccines co-expressing the co-stimulatory protein CD80 and novel immunostimulatory complexes of IL-15 and IL15Rα. These studies will provide the basis for an AML trial in patients over 60 yo, without HSCT options, who will undergo remission induction/consolidation, and randomization to post-remission vaccination, or to no other therapy. Prior AML vaccine approaches have been hampered by poor host immune responses, in part secondary to leukemia-mediated stimulation of inhibitory immune effectors such as regulatory T cells (Tregs). In older patients, anti-tumor immunity is not only limited by inhibitory Treg activity, but also by deficiencies in T cell-dependent adaptive immune responses, decreased IL-2 production and CD4 proliferation with immune stimulation,10 and age-related accumulation of senescent CD8+CD28- T cells with poor vaccine responses.11-14 Despite these deficiencies, innate immune pathways, notably cytotoxic NK and NKT cells, may be relatively preserved.15,16 Our hypothesis is that an AML vaccine expressing IL15/IL15Rα will substantially improve anti-leukemic responses and relapse-free survival by 1) better induction of primarily NK and NKT cell mediated immunity that may be somewhat preserved in the elderly, 2) more effective induction of antigen-specific cytotoxic lymphocytes (CTL) against AML, 3) greater persistence of immune responses through actions of IL15 on memory T cells, and 4) reduced stimulation of Tregs, when compared with the effects of IL2.17 The primary mechanism of IL-15 activity via trans-presentation by IL15Rα, requires co-expression of IL15 and IL15Rα in the same cell,5,18 and increases IL15 half-life/ activity through IL-2/IL15Rβγc receptors.19,20 However, it is not clear whether soluble IL15/SIL15Rα heterodimers normally in the circulation, or cell-bound IL15/IL15Rα have different efficacy, or act on different immune effector populations, particularly in the context of anti-tumor immunity. Thus, a novel aspect of these studies will be the head-to-head comparison of the relative safety, efficacy, and specificity of IL15-mediated stimulation of anti-leukemic immunity by co-expression of IL15 with IL15Rα in three different biological contexts: 1) trans-presented by cell-bound mIL15Rα, 2) secreted as a soluble complex (IL15/sIL15Rα), or 3) secreted as an IL15/IL15Rα fusion protein with super-agonist and anti-tumor activity ex vivo and in vivo in which IL15 is linked to the extracellular cytokine-binding (Sushi) domain of IL15Rα.21 The safety, efficacy, and specificity of induced immune effector responses will be evaluated both ex vivo, by co- culture of autologous human peripheral blood mononuclear cells (PBMC) with CD80/IL15/IL15Rα-modified primary AML (Aim 1), and in vivo, in a murine leukemia model (Aim 2). As a prelude to subsequent clinical studies, we will also determine whether immune stimulation by CD80/IL15/IL15Rα-engineered vaccines can partially overcome the diminished immune responsiveness of older individuals, by testing outcomes in aged mice, in parallel, in vivo studies. Although systemic IL15 administration has entered clinical trials, it causes neutropenia and other side- effects.22 Thus, a strength of this vaccine approach, especially for the elderly, is that toxicities of systemic IL15 delivery are reduced or eliminated by localized expression of IL15 in irradiated autologous whole cell vaccines. Specific Aim 1: Compare the efficiency of lentivirus mediated expression of CD80 and IL15 with cell- associated and soluble forms of IL15Rα in primary AML cells, and the specificity of ex vivo responses of human immune effector populations induced by co-culture with AML vs normal bone marrow (BM) The objective of Aim 1 is to perform preclinical studies, necessary for implementation of a clinical trial, to determine whether AML vaccines transduced with CD80, IL15, and mIL15Rα , sIL15Rα, or IL15/IL15 Rα fusion, show efficient expression, or induce off-target cytolytic responses to normal BM by autologous PBMC stimulated ex vivo. Specific Aim 2: Assess the safety and effects on overall survival of 32Dp210 vaccines expressing murine CD80, IL15, and mIL15Rα, sIL15Rα, or IL15/IL15 Rα fusion vs CD80/IL2 in young and aged leukemic mice. The objective of studies in Aim 2 is to assess anti-leukemic responses and off-target autoimmune responses (tissue damage) in young, and in immune senescent mice. Our hypothesis is that immune stimulation by CD80 and IL15 and mIL15Rα, sIL15Rα, or IL15/IL15Rα fusion will induce more effective CTL, NK, and NKT-mediated anti-leukemic effects than stimulation by CD80/IL2. AML/CD80/IL15/IL15Rα vaccines could be of particular benefit in the aged, due to reduced Treg stimulation, and enhanced activation of NK and NKT cytolytic activity that may be relatively preserved.